Bioinformatics Core Facility

Summary: For this past year, the NINDS Bioinformatics Core analysts, completed 820 analyses as part of fulfilling requests asked of them by 62 staff representing 31 different PI labs (see NIH Collaborators section).
For the requests asked of them, they included 30 different categorical types:sc/nRNA-Seq Analysis Related, RNA-Seq Analysis Related, ChIP-Seq Analysis Related, miRNA Microarray Analysis Related, Mass-Spec Analysis Related, Survival Analysis Related, PhIP-Seq Analysis Related, PacBio Long Read Analysis Related, Pathogen-Seq Analysis Related, Metabolite Analysis Related, Machine Learning Related, Protein Structure Analysis Related, TRAP-Seq Analysis Related, Training and Mentorship Related, Classical Sequence Analysis Related, Targeted Resequencing Related, Slam-Seq Analysis Related, mRNA Microarray Analysis Related, Alternative Poly Adenylation Analysis Related, Transposable-Seq Analysis Related, Protein Analysis Related, Methylation Array Analysis Related, Meta Analysis Related,
BCR-Seq Analysis Related, TCR-Seq Analysis Related, Protein Microarray Analysis Related, Nanobody Analysis Related, CRISPR Analysis Related, Antibody Analysis Related, OD Analysis Related.

Developer staff in the NINDS Bioinformatics Core have worked in support of 12 different applications for 7 different PI labs: SeqSeek (a public facing application designed to share next generation scRNA-Seq data and results), OSTRICH (The Offline System for Trials and Research Information Collection and Housing is a non-public application designed to collect and store patient data securely when there is no network connectivity), EncoMPASS (The Encyclopedia of Membrane Proteins Analyzed by Structure and Symmetry is a public facing application designed to enable a user to perform integral membrane protein query and analysis), eStroke2 and eStroke2-GO (a non-public mobile applications designed to enable hospital staff to enter and capture patient data real-time for stroke management and treatment decision), Stemcell DB (a public facing application designed to share omic data generated from the 21 hESC lines that define the NIH Human Pluripotent Stem Cell Registry along with omic data for other iPSCs and differentiated tissues), EnDovascular therapy GuidE (EDGE, is a public facing application to help determine what American Heart Association guidelines should be considered), Core Tool (a non-public application designed for automated image "core" lesion segmentation to better assess severity of stroke patients upon their presentation to the hospital and aid in treatment decision), a non-public application for animal inventory tracking, and an upgrade of the NINDS Data Hosting Site (a public facing application for sharing supplement data for manuscripts submitted by NINDS staff that the accepting Journal could not host due to size, type, and/or format). Support work provided for these applications included: systems design, front-end development, middleware development, database development, and maintenance. Developer staff also provided server-side support for the Core analyst staff.